Lung resident macrophage subsets in regulating tissue immunity - Resubmission - 1

Abstract
Tissue-resident macrophages are a diverse population of cells that perform specialized functions such
as sustaining tissue homeostasis and surveillance. We recently identified a novel subset of pulmonary
interstitial macrophages in mice and humans that localize to the lungs and are in close contacts with
the innervating nerves. These nerve and airway associated interstitial macrophages (NAMs) are
transcriptionally and developmentally distinct from the alveolar macrophages (AMs). In our influenza
studies, we found that NAMs proliferate robustly and their absence augmented the inflammatory
response following infection. However, we know little to nothing about the functions of NAMs in type 2
immune responses. Our overall goal is to characterize the specific contributions of AMs and NAMs
following infection with Nippostrongylus brasiliensis (Nb), an experimental model for type2 immunity
against helminths diseases. To this end, we propose to combine multiparametric flow cytometry and
imaging with our elegant in vivo models and cutting-edge genomic approaches such as scRNA-seq
and ATAC-seq. The first aim of this proposal will characterize specific functions of both AMs and NAMs
following an infection with Nb parasites, by using in vivo models with selective depletion of AMs or
NAMs or both. In the second aim, we will investigate the mechanisms that underpin specific functions
of NAMs in mounting a long-lived anti-parasitic immunity. We will also use genomic approaches to
unbiasedly evaluate the chromatin accessibility of AMs and NAMs and correlating transcriptomes that
allow for their critical and distinct functions. Our proposed studies will open new avenues of research
and can fundamentally change our understanding of the functions and mechanisms related to
pulmonary macrophages and can be extended to study other pulmonary diseases such as asthma,
chronic obstructive pulmonary disease (COPD) as well as the current global pandemic COVID19.

Public health relevance
Project Narrative This proposal aims to understand the developmental cues that drive differentiation of subsets of pulmonary macrophages critical during tissue homeostasis as well as protection during infection. Findings from our study has the potential of identifying novel therapeutic targets for engaging innate and adaptive immune responses in protection against influenza infection, hence disseminating larger gaps in the understanding of macrophage driven host-pathogen interactions.